Shared Resource Management

PROJECT SUMMARY / ABSTRACT
Roswell Park Comprehensive Cancer Center (Roswell Park) operates nine Cancer Center Support Grant
(CCSG) shared resources and eight institutionally supported shared resources. All 17 shared resources are
centrally managed through the Shared Resource Management Office (SRMO), a division of our Research
Support Services Department. The mission of the SRMO is to provide exceptional service delivery within the
shared resources to our members. All SRMO personnel are members of the CCSG administration team. The
SRMO, CCSG Administration, and Shared Resource Advisory Committees (SRACs) oversee, guide, and
support the Shared Resource Directors and appropriate Associate Directors in enabling access to advanced
research technologies and technical capabilities for all CCSG members. During the project period, Roswell Park
reconfigured the CCSG shared resources to facilitate stronger leadership, streamlined processes, and improved
financial oversight. In consultation with the CCSG External Advisory Board, and each of the SRACs, the SRMO
consolidated the services and leadership of 8 shared resources into 4 combined CCSG shared resources to
strategically align better with the needs of our CCSG members. The SRMO facilitates consolidated/centralized
billing, operational guidance, human resources support, equipment and service line management, and support
for the marketing of services offered by the individual shared resources.
The Specific Aims for Shared Resource Management are:
AIM 1: To provide comprehensive oversight for Roswell Park shared resources, with the goal of effectively
managing strategic alignment, operations, marketing, and training.
AIM 2: To evaluate the need for new specialized technologies, services, and expertise that enhance scientific
interactions and productivity.
AIM 3: To engage with shared resource leaders and invest in service delivery and purchase of new equipment
that leads to cost-effective, reliable, and quality-controlled processes.
AIM 4: To establish policies for shared resource access, use, and financial management thereby ensuring
appropriate services are available and cost effective for all CCSG members.
The SRMO plans to continue to provide administrative, financial, and oversight management and exceptional
support to our CCSG members. Roswell Park places a strong focus on advanced technologies to maintain our
status as leaders in cancer research and patient care. In support of our strategic plan, the SRMO will continue
to the support existing shared resources and facilitate the development of new shared resources and services
in areas such as metabolomics, current good manufacturing practices (cGMP), community engagement, and
software development.